The kallikrein-kinin system in endothelial progenitor cell homing in arthritis

DESCRIPTION (provided by applicant): Project Summary/Abstract Synovial neovascularization plays a critical role in the pathogenesis of rheumatoid arthritis (RA) and is required for inflammatory cell infiltration, expansion of synovial cells and pannus formation. Understanding the mechanisms that control neovascular process is important because it will identify key molecules as targets for pharmacologic blockade by specific inhibitors and receptor antagonists. Recently, it has been noted that endothelial progenitor cells (EPCs) are recruited to inflamed synovium and participate in synovial neovascularization in arthritis. The mechanism for EPC homing, however, remainsunknown and the following important issues need to be addressed: How are EPCs regulated under the inflammatory conditions in arthritis ? What are the cellular and molecular mechanisms for EPC homing to inflamed synovium ? How do EPCs differentiate into new blood vessels and to what extent do they contribute to synovial neovascularization ? Clinical and experimental arthritis is associated with in vivo activation of the plasma kallikrein-kinin system (KKS). Bradykinin, the activation product of the KKS, mediates inflammatory response in arthritis through its receptors B1R and B2R. The applicant has recently found that EPCs express B2R, and bradykinin stimulates transendothelial migration of EPCs. In this R03 proposal, the central hypothesis is that activation of the KKS, via the release of bradykinin, stimulates synovial recruitment of EPCs in arthritis. This hypothesis is innovative because in the synovial neovascularization, the role of the KKS, which is a primary mediator of inflammation, is unclear. In the proposed studies, animal models, cell biological, pharmacological, biochemical and molecular approaches will be used. The hypothesis will be tested through the pursuit of the following two specific aims: Specific Aim 1 will determine whether activation of the KKS stimulates EPC homing to inflamed synovium and participation in synovial neovascularization in arthritis. The applicant has succeeded in isolating EPCs from Lewis rats and detecting synovial recruitment of implanted EPCs. Association of the KKS activation with EPCs-mediated new vessel formation will be examined by using plasma kallikrein inhibitor, anti-kininogen antibody and kininogen deficient animal model. Specific Aim 2 will define the role of bradykinin receptors, B1R and B2R, in synovial recruitment of EPCs. The effect of bradykinin on synovial recruitment of EPCs will be evaluated in a rat model of knee joint perfusion. The applicant will also test whether upregulation of kinin receptors potentiates bradykinin-stimulated homing of EPCs. The role of each kinin receptor in synovial recruitment of EPCs will be determined by using specific antagonists or gene silencing of kinin receptors. These proposed investigations will not only initiate further studies of the cellular and molecular mechanisms for EPC homing and differentiation in arthritis, but will also improve in depth understanding of the pathophysiological role of the KKS in synovial neovascularization. PUBLIC HEALTH RELEVANCE: Project Narrative Synovial neovascularization is critical for the pathogenesis of rheumatoid arthritis. The proposed research examines the regulation of endothelial progenitor cells (EPCs) by plasma kallikrein-kinin system and determines the contribution of EPCs to synovial neovascularization. This project will provide novel insight into the mechanism of synovial neovascularization and will identify potential therapeutic targets for treatment of arthritis.

Public health relevance
Project Narrative Synovial neovascularization is critical for the pathogenesis of rheumatoid arthritis. The proposed research examines the regulation of endothelial progenitor cells (EPCs) by plasma kallikrein-kinin system and determines the contribution of EPCs to synovial neovascularization. This project will provide novel insight into the mechanism of synovial neovascularization and will identify potential therapeutic targets for treatment of arthritis.